Mentoring Patient-Oriented Research in Deep Lipid Phenotyping for Cardiovascular Disease

Project Summary
Dr. Anand Rohatgi is a Professor in the Department of Internal Medicine/Division of Cardiology at UT
Southwestern Medical Center. He has established a successful and independent research program focused
on elucidating the role of HDL metabolism in cardiovascular disease. His experiences as an active clinical
cardiologist, translational researcher, and mentor have positioned him to be an ideal candidate for renewal of
the K24 Mentoring Career Development Award. His clinical focus on preventive cardiology, especially in the
South Asian population, have paved the way for a synergistic translational research program focused on HDL
metabolism and atherosclerotic CV disease and a passion for mentoring trainees and faculty. Dr. Rohatgi has
applied both epidemiologic and translational POR to this objective, resulting in a number of published
observations that have moved the field forward with respect to insights into pathophysiology and refinement of
HDL-related markers for risk prediction and as targets of therapy. This work has been supported by continuous
funding from the NIH/NHLBI (K08>R01>R01), the AHA, and industry. During the K24 funding period, he has
mentored 25 trainees (some ongoing), resulting in 8 first-author papers, multiple meeting presentations, two
AHA Post-Doctoral Fellowship Awards, a tenure-track faculty position, and several K and R submissions.
Overall, sixteen of Dr. Rohatgi's total mentees are women. In addition, during the K24 funding period, Dr.
Rohatgi launched a new South Asian Heart Clinic, began a pilot prospective POR study in this population, and
is PI on an R01 studying lipid metabolism in South Asians (2022-2027). The K24 renewal award will support
Dr. Rohatgi's scientific career activities by allowing him to engage in professional development via
coursework/training and execution of novel projects that will enhance the primary aims of his R01s and support
future independent funding. In addition to supporting scientific career activities, the K24 renewal award will
directly allow Dr. Rohatgi to pursue mentorship/leadership training and enhance his ability to more deeply
engage with specific mentees pursuing K and R01 awards and more broadly engage with all mentees in
cardiovascular training. In the renewal period, in addition to established mentoring roles, Dr. Rohatgi will be
leading R01 grant workshops and provide mentor coaching to faculty applying for K and R grants. The overall
scientific aims of this proposal are to: 1) Determine the contribution of genomic factors to variability in HDL
function; 2) Identify disease-relevant protein-based HDL subspecies and determine their role in
cardiometabolic disease; 3) Determine the association between advanced measures of lipoprotein metabolism
and cardiometabolic phenotypes in South Asians.

Public health relevance
Project Narrative Reverse cholesterol transport is a key mechanism preventing atherosclerotic heart disease. We are investigating the genetic and molecular basis of what drives reverse cholesterol transport to better identify novel strategies to reduce heart disease risk overall, and specifically, in South Asians. This project will train junior investigators on using patient-oriented research to improve heart health.